Antibiotic treatment failure of Klebsiella pneumoniae liver abscesses

Over the past three decades, a distinctive pathotype of tissue-invasive hypervirulent Klebsiella
pneumoniae (hvKp) has gained attention for its capacity to induce severe infections, such as
wound infection and liver abscesses in healthy individuals. Despite appropriate antibiotic
therapy, treatment of hvKp liver abscesses is frequently ineffective, leading to complications
such as recurrent bacteremia, metastatic infection, or mortality. Despite the clinical significance
of hvKp liver abscesses, the bacterial factors necessary for abscess formation and the cause of
inadequate antibiotic efficacy are poorly understood. Populations of antibiotic-tolerant cells,
defined as phenotypic variants capable of surviving antibiotic challenge, have been implicated in
treatment failure of infections caused by other pathogens. However, the contribution of
antibiotic-tolerant cells to the treatment failure of hvKp infections is unknown.
We have established a novel mouse model of hvKp wound infection which results in systemic
infection, including liver abscesses. Initial findings indicate that that clinically relevant antibiotics
used to treat hvKp infections, are very effective against wound infection but have poor efficacy
against liver abscesses. Treatment failure was not associated with antibiotic resistance but
could be a result of inadequate drug penetration or the enrichment of antibiotic tolerant cells
within abscesses.
In Aim 1 of this proposal, we will employ a combination of quantitative and imaging mass
spectrometry to visualize antibiotic distribution into infected livers and decipher the contribution
of antibiotic tolerant cells and/or poor drug penetration to treatment failure in this niche. In Aim 2,
we will employ RNA sequencing to examine the transcriptional profile of hvKp in the wound
infection compared to liver abscesses and assess the ability of mutants in key virulence factors
to establish infection. Understanding the factors required to form liver abscesses and the
precise nature of treatment failure against abscess populations will aid in future therapeutic
development against this clinically challenging indication.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Classical Klebsiella pneumoniae infections are a significant concern in healthcare settings, but the emergence of hypervirulent Klebsiella pneumoniae (hvKp) poses an increased threat due to its ability to cause severe invasive infections in healthy individuals. Notably, antibiotic therapy has shown limited efficacy against hvKp liver abscesses, leading to recurrent bacteremia, metastatic infections, and mortality. The reasons for treatment failure are unclear, and this project aims to investigate the bacterial factors required to form abscesses and subsequently survive antibiotic therapy.